Integrating 1H MRS with 2H-Labeled Glucose to Characterize Dynamic Glutamate Metabolism in Major Depressive Disorder

PROJECT SUMMARY/ABSTRACT
Major depressive disorder (MDD) is a brain-based disorder that affects nearly 300 million people worldwide.
Recent theoretical models and empirical studies have highlighted glutamate (Glu) as a key neurotransmitter in
the pathophysiology of MDD that may be an important target for novel antidepressants. Using proton magnetic
spectroscopy (1H MRS), several studies have identified lower concentrations of Glu and other related metabolites
(e.g., glutamine, Gln) in depressed patients in anterior cingulate cortex (ACC). However, given the dynamic
nature of the Glu–Gln cycle (Glu can be metabolized in neurons as part of the tricarboxylic acid [TCA] cycle or
synthesized into Gln, which is a precursor to both GABA and Glu, in astrocytes), it is critical to generate novel
imaging methods that will clarify which aspects of Glu metabolism underlie MDD. Doing so will advance our
understanding of MDD and elucidate the mechanisms underlying fast-acting antidepressants targeting
glutamatergic neurotransmission (e.g., ketamine). In this context, carbon-13 (13C) MRS with 13C-labeled
substrates has been the only method to evaluate the Glu–Gln cycle, but this method has limited clinical
applications due to significant technical challenges. Deuterium (2H) metabolic imaging has also been recently
presented as a tool for detecting Glx (Glu+Gln) following oral administration of deuterated glucose (2H-glucose),
as this method contains higher overall sensitivity compared to 13C MRS but is unable to resolve Glu from Gln.
Thus, the goal of the present proposal is to develop an interleaved 1H/2H MRS acquisition combined with 2H-
glucose on a 7T scanner to establish the reliable detection of Glu metabolism in patients with MDD. In Aim 1,
we will develop the dynamic imaging protocol to obtain reliable measures of Glu metabolism following oral 2H-
glucose intake. Our benchmarks for determining the optimal dynamic acquisition protocol will be based on
maximizing signal-to-noise ratios of 1H Glu, 1H Gln, and 2H Glx and temporal resolution (time per block of 1H or
2H MRS) and determining the time course when kinetic curves for label exchange reaches steady-state. We will
validate our optimized protocol in an independent sample of patients with MDD and age- and sex-matched
healthy controls and hypothesize that both groups will exhibit comparable test-retest reliability (repeatability
coefficient > 0.95). In Aim 2, we will develop methods to fit a simplified kinetic metabolic model to estimate the
rates of TCA and Glu–Gln cycling, and will test the hypothesis that MDD is characterized lower baseline (as
measured during the pre-glucose acquisition) levels of Glu and Gln, and slower Glu metabolism (as measured
by the metabolic cycling rates) in ACC. The novel imaging protocol and the metabolic metrics we develop will
stimulate innovative research on elucidating the mechanisms of fast-acting antidepressants targeting
glutamatergic neurotransmission (e.g., ketamine).

Public health relevance
PROJECT NARRATIVE Recent theoretical models and empirical studies have highlighted glutamate as a key neurotransmitter in the pathophysiology of depression that may be an important target for novel fast-acting antidepressants. However, given the dynamic nature of the metabolism of glutamate (which can be metabolized as part of the Krebs cycle in neurons or converted to glutamine in astrocytes via mitochondrial enzymes), it is critical to develop novel imaging methods that will clarify which aspects of glutamatergic metabolism is altered by depression. Thus, the goal of the present study is to establish the reliable detection of dynamic glutamate metabolism in depressed individuals using proton and deuterium magnetic resonance spectroscopy at ultrahigh magnetic fields (7 Tesla) combined with oral intake of deuterated glucose and to develop novel metabolic metrics that will provide insight into this debilitating condition.